INTEGRATED ANALYSIS OF HETEROGENEOUS COVID-19 DATASETS USING KNOWLEDGE GRAPH.

The goal of this study is to construct COVID-19 Dataset Knowledge Graph (COVID-DKG) and to demonstrate its uses in COVID-19 research and development.